NIDCR DIR Scientific Cores (Combined Technical Research Core)

The NIDCR DIR Scientific Cores provide scientific research support for intramural investigators performing studies and experiments on dental, oral and craniofacial diseases.

The Combined Technical Research Core (CTRC)is in its 12th year of operation. CTRC provides access to state-of-the-art research technologies, scientific expertise, and technical support to enhance the research efforts of all NIDCR DIR investigators. The services that it offers include the following:

1)Flow and Spectral Cytometry; Trained 12 new investigators and students during this period on the Cytometry analyzers, and 5 investigators on the spectral analyzer. Total hours used by investigators was over 2510 hours between the three cytometry analyzers which was an increase of 20% over the previous year.

3)FACS Cell Sorting; FACS sorted over 800 hours for 18 investigators approximately 30% increase over the previous year.

4) Cell Elutriation have elutriated tota1 of 68 cell types including Monocytes, PBMC, Platelets, and T-Cells.

5) Histology; Performs tissue processing, sectioning and staining for NIDCR investigators working on almost 370 samples/tissues.

6) Image; Have trained over 25 new investigators in the use of ScanScopes, Nanozoomer and CeligoS with the usage of over 400 hours.

CTRC projects increase in demand of its services and resources for the next fiscal year as it has recently trained a few investigators on the Analyzers, Image instruments, and has trained more investigators on the Spectral Analyzer and new Image scanner.